Molecular and Cellular Mechanisms of the Aberrant Type I Interferon Response in VEXAS Syndrome

PROJECT SUMMARY/ABSTRACT
VEXAS (Vacuoles, E1-ubiquitin-activating enzyme, X-linked, Autoinflammatory, Somatic) is a somatically
acquired X-linked disorder characterized by autoinflammatory and hematologic manifestations. First reported in
2020, VEXAS is now known to afflict ~1 in 4,269 men older than 50 years old and causes multiorgan
autoinflammation and high rates of myelodysplastic syndrome (MDS). VEXAS is caused by a missense mutation
in the ubiquitin-activating enzyme 1 (UBA1) gene that results in aberrant clonal expansion of mutant
hematopoietic stem cells (HSPCs) and their myeloid, but not lymphoid, progeny. UBA1 is one of only two E1
enzymes that initiate the ubiquitylation cascade. The most prevalent VEXAS mutations occur at the M41T codon
and impair translation initiation at Met41 of the cytosolic UBA1 isoform (UBA1b) and lead to aberrant Met67-
initiated translation to generate the enzymatically impaired UBA1 isoform, UBA1c. How this switch in UBA1
isoform usage triggers VEXAS pathogenesis at the molecular and cellular levels remains unknown, owing to the
lack of genetically engineered cell culture and animal models. Deploying a newly developed base-editing
method, we have succeeded in recreating the most common mutation in UBA1 observed in VEXAS in primary
macrophages and HSPCs. Using these systems, we have observed a hyperactive IFN-I axis and spontaneous
myeloid bias of UBA1-mutant HSPCs ex vivo and in vivo. Given the links between type I interferon and
hematopoiesis, these preliminary results lead us to hypothesize that UBA1 mutation may drive VEXAS
pathogenesis through dysregulated interferon signaling and its consequent influence on hematopoiesis.
In Aim 1, I propose to dissect the molecular mechanisms by which UBA1 mutation affects type I interferon
signaling. Accordingly, we will biochemically dissect IFN-I induction pathways in VEXAS macrophages and test
whether Uba1-mutant HSPCs, like their myeloid progeny, display altered IFN-I production. We will further assess
the ubiquitylation status of signaling components downstream of innate immune signaling pathways in
macrophages bearing a Uba1 mutation to identify mechanisms by which aberrant ubiquitylation may dysregulate
IFN-I production in VEXAS. In Aim 2, I will dissect mechanisms of myeloid-biased hematopoiesis in VEXAS
syndrome. Accordingly, I will interrogate whether IFN-I signaling differentially affects normal versus UBA1-mutant
HSPCs ex vivo. In addition, we will evaluate enhanced myelopoiesis of UBA1-mutant HSPCs in vivo and directly
test the contribution of dysregulated interferon to the myeloid-biased hematopoiesis associated with VEXAS.
Collectively, our work will provide key insights into VEXAS pathogenesis using state-of-the-art genetic models
and may therefore identify novel therapeutic targets in this disease of major unmet medical need.

Public health relevance
PROJECT NARRATIVE VEXAS (Vacuoles, E1-ubiquitin-activating enzyme, X-linked, Autoinflammatory, Somatic) syndrome is a newly reported and severe hematologic-autoinflammatory syndrome afflicting an estimated ~1 in 4,269 men older than 50 years. Despite its severity and prevalence, molecular mechanisms underlying VEXAS pathogenesis remain poorly understood owing to a lack of genetically engineered cell culture and animal models. This proposal reports the development of novel genetically engineered models of VEXAS that will enable us to examine the mechanisms and interplay between aberrant interferon-mediated inflammation and myeloid-biased hematopoiesis in this disease.